Systematic analysis of the actin cytoskeleton and directed cell migration

Abstract:
Cell motility is arguably the oldest problem in cell biology as the movement of cells was one of the first things
noted when the microscope was developed in the 17th century. The last sixty years of work revealed that the
molecular underpinnings of motility involve the active control of the cytoskeleton. However, many questions
remain unanswered. While we have identified many of the components of the cytoskeleton and know a great
deal about their biochemical and structural characteristics, we lack a systematic understanding of how the
parts interact to produce coordinated cytoskeletal function such as during cell migration. Perhaps the most
important problem in cell motility is understanding how cells perceive various cues in their environment and
convert this information into a directed migration response. A deeper understanding of these two inter-related
problems will inform higher order biological processes such as embryogenesis, immune response and wound
healing, as well as diseases such as cancer metastasis. In 2012, our published a watershed paper for our
research program that has shaped the course of our work ever since (Wu et al, Cell). In this paper, we
discovered that mammalian fibroblasts could be nearly completely depleted of Arp2/3 by RNAi without
significantly compromising viability. This allowed us to go the heart of the problem and study the function of the
Arp2/3 complex directly. Using these cells and microfluidic devices to produce long-lasting gradients, we made
the surprising observation that cells did not need the Arp2/3 complex for chemotaxis, but absolutely required it
for haptotaxis. Inspired by our success with RNAi, we shifted to a conditional knockout mouse model where the
gene encoding the critical Arpc2 (p34) subunit of Arp2/3 could be deleted on command. Using these tools, we
have pursued two goals: 1) Investigate how cells can build an actin cytoskeleton without the Arp2/3 complex
(funded by RO1 GM111557) and 2) Interrogate the molecular mechanisms of directed cell migration of
mesenchymal cell and other cell types (funded by RO1 GM110155). Building on our progress in the last five
years, we propose to extend our work in these two areas by defining the roles of Arp2/3 and non-Arp2/3 actin
networks in contributing to cell behaviors such as directed migration towards chemical (chemotaxis), substrate-
bound (haptotaxis) and mechanical (durotaxis) cues.

Public health relevance
PROJECT NARATIVE: Cell migration is essential for many physiological processes such as wound healing, immune response and morphogenesis, and plays a significant role in pathological processes such as cancer metastasis and cardiovascular disease, the two leading causes of death in the developed world. Despite its clear importance in normal human health and disease states, no therapeutic treatments directly target this process. This is mainly due to deficiencies in our knowledge about the mechanisms of the cytoskeleton and cell migration. We propose to address some of these deficiencies using a multi-disciplinary approach involving molecular perturbations, microfluidics, cutting-edge microscopy and image analysis. These studies will directly contribute to understanding of disease states such as tumor metastasis, fibrosis and cardiovascular disease, and to our understanding of normal physiological processes such as wound repair.